Preventing Infections and Antimicrobial Resistance in the Aging Population: Translational Research and Training Program

ABSTRACT
Frail older adults in institutional settings such as hospitals and nursing homes (NHs) are at a particularly high
risk of poor outcomes. Translation of research findings into clinical practice, particularly in NHs, is
challenging. Educating and training a multidisciplinary group of junior investigators is key to designing
evidence-based, randomized studies to test innovative models and practices that reduce infections and
antimicrobial resistance in NH settings. In order to continue her well-established translational research, Dr.
Lona Mody, Amanda Sanford Hickey Professor of Internal Medicine at the University of Michigan, is
submitting this K24 renewal proposal. Dr. Mody’s career objective is to develop a nationally and internationally
recognized program in infection prevention among susceptible populations. She will achieve this objective by
conducting patient-oriented research that improves outcomes from infectious diseases and reduces
transmission of bacterial and viral infections in a vulnerable older population and by educating and training a
multidisciplinary group of mentees. The majority of her professional life has been dedicated to the conduct of
patient-oriented research. During the past 5 years, she has published 90 papers, including six articles
pertaining to career development and work-life balance. Fifty-three were as first or senior author (59% of 90)
and 59 publications were mentor/mentee collaborations (66% of 90). Several of her mentees have received
career development awards including GEMSSTAR, K awards and institutional career development grants
leading to independent academic careers and tenure track positions. She has established a steady stream of
research funding and effective mentorship, with continued collaboration throughout the course of mentees’
careers.
Dr. Mody’s research brings together expertise in geriatrics and aging research, microbiology and infectious
diseases, epidemiology, outcomes research, nursing, and others. Her work on reducing infections and
antimicrobial resistance in vulnerable populations grows out of work originally funded by the NIA, AHRQ,
CDC, T. Franklin Williams Scholarship (now known as GEMSSTAR), and the Hartford Foundation. Several
currently funded grants will serve as the platform for this grant proposal, including ongoing work funded by
NIH, AHRQ, VA, and the Kahn Foundation. These studies will yield rich datasets and banked microbes that
will be utilized to educate and train mentees in patient-oriented research with extensions to molecular
epidemiology and community-based participatory research. Resources supporting the education, training, and
development include the University of Michigan Medical School, VA Ann Arbor Healthcare System, UM
Department of Medicine, UM Department of Surgery, Michigan Institute for Clinical and Health Research
(MICHR, UM-CTSA), UM OAIC Pepper Center, and the UM School of Public Health.

Public health relevance
PROJECT NARRATIVE Infections and antimicrobial resistance are common in older adults and commonly lead to poor outcomes. The overarching goal of this proposal is to train the next generation of multidisciplinary researchers who will advance the field of infection prevention in older adults and make healthcare safer. We expect our results to shift the evolving paradigm of infection control and prevention in long-term care institutions and hospitals through designing effective, efficient, and targeted infection control programs for frail older adults.